University of Pennsylvania Patient-derived Xenograft Development and Trials Center

Summary:
The goal of the Administrative Core of the University of Pennsylvania PDX Development and Trials Center is
primarily to facilitate innovative translational science that will accelerate the application of new discoveries to
the clinic for cancer patients. This will be achieved through a combination of enhancing both the development
of unique PDX models at UPENN and through facilitating interaction with the PDXNet. The Administrative
Core will be responsible to make sure that the UP-PDTC acts effectively as a research unit of PDXNet. The
primary responsibilities of the Administrative Core are to provide scientific leadership, administrative services,
and financial oversight, as well as to function as a communication hub for all UP-PDTC-related activities. The
Administrative Core will support investigators and personnel in Projects 1-2, the PDX Core, the Pilot Projects
and Trans-Network Core, and the Biostatistical Core. The Administrative Core will arrange at least annual
meetings of the SAB of the UP-PDTC. Of note, the Administrative Core coordinates all efforts in support of
diversity, equity, and inclusion, including ensuring and facilitating wide representation of all minority groups in
the tissue banks and PDX models developed by the UP-PDTC. The Administrative Core provides each of
these groups with centralized organization and support for their activities, and helps each group stay informed
about activities, meetings, opportunities, and other information pertinent to the UP-PDTC. The Administrative
Core will be responsible for communication with PDXNet personnel (PDXNet Steering Committee) as well as
NCI personnel and will provide support for all collaborations. In particular, the Administrative Core will facilitate
interactions between UP-PDTC personnel and the PDXNet Data Commons and Administrative Center.
Continuity of support provided by the staff will result in efficient and effective administration for the UP-PDTC.